The Role of Gab2-MALT1-mediated cell signaling in venous thrombogenesis

Venous thromboembolism (VTE), which comprises deep vein thrombosis (DVT) and pulmonary embolism (PE),
is the third most common cause of vascular death after a heart attack and stroke. VTE is responsible for 300
000 deaths annually in the USA alone. Although the development of direct oral anticoagulants has improved the
treatment of VTE, there are still significant bleeding risks associated with anticoagulant therapy. A better
understanding of the pathogenesis of VTE would aid in developing novel, effective and safer drugs. Although
the etiologic factors of DVT codified by Virchow’s triad, i.e., hypercoagulability, blood stasis, and endothelial cell
dysfunction, are still relevant, recent studies suggest that DVT is primarily a thromboinflammatory-mediated
event. This opens a new possibility that suppression of thromboinflammation may be an ideal approach to
prevent and treat VTE. The endothelium is an important contributor to thromboinflammation in DVT. Our recent
studies show that Gab2 (Grb2-associated binder2), a signaling adapter protein, plays a central and key role in
integrating inflammatory signaling initiated by diverse inflammatory stimuli in endothelial cells. Our studies
identify for the first time that Gab2 mediates the assembly of the CBM (CARMA3-BCL10-MALT1) signalosome
in endothelial cells in response to inflammatory stimuli. Gab2-mediated CBM signalosome not only leads to the
activation of NF-kB and prothrombotic gene expression but also exocytosis of P-selectin and VWF via activation
of the Rho signaling pathway. In vivo studies show that global deficiency of Gab2 or inhibition of MALT1 in the
CBM signalosome by specific pharmacological inhibitors protects against LPS- and S. pneumoniae infection-
induced inflammation and inferior vena cava (IVC) ligation-induced venous thrombosis. These studies identify
novel inflammatory signaling mechanisms and suggest they could play a crucial role in venous thrombosis.
However, many knowledge gaps exist still in our understanding of these mechanisms and their contribution to
VTE. We hypothesize that endothelial Gab2-MALT1-mediated signaling plays a crucial role in
thromboinflammation and contributes to the pathogenesis of VTE and targeting Gab2-MALT1 signaling by
pharmacological inhibition of MALT1 will have therapeutic potential in preventing and treating VTE. The specific
aims are to (1) elucidate molecular mechanisms by which Gab2 mediates thromboinflammatory signaling
in endothelial cells, (2) determine the role of endothelial Gab2-MALT1 signaling in venous thrombosis
using cell-specific Gab2 and MALT1 knockout mice, (3) assess the influence of the Gab2-MALT1
signaling on venous thrombus resolution and vein wall injury. The proposed studies will employ innovative
experimental approaches and unique transgenic mice Impact: Our proposed studies will provide novel insights
into thromboinflammatory signaling in endothelial cells and other relevant cell types. Elucidating the role of Gab2-
MALT1-mediated signaling in thromboinflammation and venous thrombosis would aid in developing novel and
ideal therapeutic drugs to prevent and treat VTE without increasing bleeding risk.

Public health relevance
PROJECT NARRATIVE Inflammation contributes to venous thrombosis, and suppression of inflammation may prevent or resolve venous thrombosis. The current proposal investigates the mechanism by which a newly identified inflammatory signaling pathway promotes venous thrombosis. The knowledge gained from our proposed studies will provide new insights into how inflammation contributes to thrombosis and aid in developing new drugs to treat venous thrombosis without increasing bleeding risk, a common problem associated with current anticoagulation therapy.